Role of Ubiquitin Ligases and Deubiquitinases in Host Defense against Mycobacterium tuberculosis

Project summary
One mechanism that is central to innate immunity against intracellular pathogens such as Mycobacterium
tuberculosis (Mtb) is engagement and targeting of bacteria for degradation by the cellular ubiquitination
machinery, a process that also directly impacts immune responses. Ubiquitin ligases expressed by host innate
immune cells attach the protein ubiquitin to intracellular pathogens or the organelles containing them, and such
ubiquitination events then trigger recruitment of the host autophagy-lysosomal degradation machinery to engulf
and destroy the invading pathogen. Ubiquitin ligases such as SMURF1 and PARKIN tag Mtb-containing
structures for autophagic degradation in a process termed xenophagy. Conversely, host deubiquitinating
enzymes (DUBs) may remove these ubiquitin tags, potentially aiding the pathogen's survival. A major gap in our
understanding of the cellular mechanisms of xenophagy is that we do not have a complete understanding of the
mechanisms of ubiquitin attachment and removal from Mtb, and we hypothesize that the extent of Mtb
ubiquitination, mediated by the relative balance between the activities of ubiquitin ligases and deubiquitinases,
directly impacts the outcome of Mtb infection. Bridging the knowledge gap around the roles of individual ubiquitin
ligases and DUBs may yield novel strategies for host-directed therapies, crucial in the current climate of growing
antibiotic resistance. Here, we will apply genetic, biochemical, immunologic, transcriptomic and animal
approaches to determine the functional role of specific ubiquitination and deubiquitination mechanisms in the
context of Mtb infection. Thus, in the proposed research we will: (1) Elucidate the role of ubiquitin ligases
SMURF1 and SMURF2 in targeting Mtb for autophagy and how they regulate interferon-β production during
infection. (2) Delineate the roles of K63 and K48 deubiquitination during macrophage infection, focusing on the
K63-specific DUB USP15 and the yet unidentified DUBs responsible for K48 deubiquitination, critical steps that
negatively regulate autophagy. (3) Determine the function of linear M1-ubiquitination by the LUBAC system and
its negative regulation by the DUB CYLD in cellular immunity to Mtb. The proposed work is expected to identify
the molecular mechanisms that target Mtb for degradation and host proteins whose activities regulate protective
immune responses.

Public health relevance
Project Narrative One mechanism leveraged by cells to destroy intracellular pathogens, including Mycobacterium tuberculosis (Mtb), is engagement of the autophagy machinery to envelop and degrade bacteria. An early step in this process is the attachment of the small protein ubiquitin to Mtb associated structures by host cell ubiquitin ligases, a process that can be countered when ubiquitin is removed by deubiquitinating enzymes. We hypothesized that the extent of Mtb ubiquitination, mediated by the relative balance between the activities of ubiquitin ligases and deubiquitinases, would directly impact the outcome of Mtb infection. Our innovative approach will dissect the dynamics of ubiquitin attachment and removal by specific ubiquitin ligases and deubiquitinases we have identified as having critical roles in regulating autophagy and cellular immunity to Mtb. This study, through its exploration of the cellular machinery essential for control of Mtb infection, aims to contribute significantly to our understanding of innate immunity and potentially identify new therapeutic targets addressing the urgent need for innovative treatments in the wake of rising antibiotic resistance in Mtb.